SILOS: Structural Inequities across Layers Of Social-Context as Drivers of HIV and Substance Use

PROJECT SUMMARY
Racial, ethnic, and sexual and gender minority populations are disproportionately impacted by HIV and
substance use, with Black men who have sex with men (BMSM) and Black transgender women (TW) bearing a
disproportionate burden. However, researchers have yet to synthesize a rigorous and holistic view of how
individual and complex factors interact to produce health disparities among minority populations. Therefore,
understanding the drivers of health disparities requires a novel approach – one which seeks to understand the
social and contextual systems around the most marginalized populations – as it is only through an individual's
interactions with their social context that any advantage or disadvantage is conferred. In line with RFA-DA-23-
061, this project proposes innovative observational research across five US cities in order to better understand
the social contexts of racial, ethnic, and sexual and gender minority populations, as well as how inequities in
those social contexts drive HIV and substance use. Specifically, through in-depth remote network surveys of
2700 racially diverse young men who have sex with men and transgender women (YMSM-TW), we will
examine how an individual's social position determines the people and the places they have access to, as well
as how supportive or risky these social and contextual environments are and how these connections might
pool risk and provide fewer resources to those with marginalized and multiple marginalized identities. In this
work we are guided by our systems framework which has been integrated with a literature on how stigma
maintains dominance by keeping marginalized populations in, out, and away. We also have a robust plan for
community engagement – which includes a Community Engagement Core, the building of Community Advisory
Boards across each of our five cities, and the utilization of our models to produce tangible targets for public
health intervention. Our approach is well-informed by our prior work. In particular, we hold ample expertise in
the modeling of the sexual networks of young racially diverse MSM and TW. Furthermore, this study builds off
our prior project chiSTIG where our team is using existing empirical data and community input to create
Chicago-specific simulations of how racial differences in how YMSM and transgender women co-locate shapes
sexual partnership in ways that pool risk for the most marginalized individuals. Furthermore, our approach is
enabled by our expertise in network data capture, specifically our leadership of Network Canvas, an NIH-
funded free and open-source network data capture tool. These experiences, as well as our skill in building and
leading strong transdisciplinary teams, make this work feasible. Taken together, this project is well-suited to
transform the scientific understanding of structural drivers of disparities in HIV and substance use.

Public health relevance
PROJECT NARRATIVE This project provides a comprehensive study of the many social and structural factors leading to racial/ethnic differences in HIV transmission and substance use among young men who have sex with men and transgender women (YMSM-TW). Using complex social network modeling and in-depth network surveys of 2700 racially diverse YMSM-TW across five US cities, it will offer a thorough account of how structural forces shape opportunity and risk through population-level differences in connections to people and places. Strengthened by a robust plan for community engagement, this work will help produce tangible targets for public health interventions and transform understanding on drivers of disparities.